Muscular Dystrophy Specialized Research Center

OVERALL SUMMARY
The overall goal of the University of Iowa Wellstone Muscular Dystrophy Specialized Research Center
(MDSRC) is to perform research on muscular dystrophies (called dystroglycanopathies) that arise from
absence or reduction in matriglycan on α-dystroglycan (α-DG). Dystroglycanopathies are a group of
congenital/limb-girdle muscular dystrophies that lead to progressive skeletal muscle weakness and a decline in
respiratory function. Project 1 (Campbell and Richerson) using mouse models of dystroglycanopathy will
define the cellular and molecular mechanisms that underlie respiratory complications. Additional studies will
determine the relationship between matriglycan length, laminin binding and α-DG receptor dysfunction in
respiratory muscles; they will also determine the ability of potential therapies already in clinical trials to restore
full-length matriglycan and normal respiratory function. Project 2 (Mathews and Saade) will define the natural
histories of FKRP-related and non-FKRP-related dystroglycanopathies derived from an established, unique
cohort of patients using established and evolving clinical measures, to optimize clinical care and facilitate
clinical trial design, with a focus on those who might be excluded from current trials due to rare genotypes,
young age or advanced disease. Extended follow up of non-FKRP genotypes will identify cohorts that share
similar rates of motor progression who might be studied together in gene non-specific clinical trials. Novel
potential biomarkers (electroretinograms and urine proteomics) identified in pilot work will be tested for
relationship to motor manifestations. Core A (Campbell and Moore) is an administrative core that will
coordinate the activities within and outside the Center to promote an interactive and collaborative research
environment, and to engage patients in muscular dystrophy research. Core B (Moore), a Muscle-Tissue/Cell-
Culture/Diagnostics Core, will support Projects 1 and 2, serve as a national tissue and cell-culture resource for
research, provide specialized diagnostic testing for a wide range of muscular dystrophies, and maintain the
infrastructure needed to evaluate muscle biopsies in support of clinical trials. Finally, Core C (Mathews and
Campbell) will coordinate our Training initiatives. This Core will support basic science and clinical research
training for medical students, postdoctoral trainees, graduate students, and undergraduate students who will
conduct research in the Center and participate care of patients. Dr. Mathews and Saade will provide clinical
research mentorship, Dr. Campbell will provide basic science training, and Dr. Moore will mentor
neuromuscular pathology students. Core C will engage the wider MDSRC and neuromuscular disease
communities by sponsoring annual symposia in coordination with the patient and family conference and by
hosting pediatric muscular dystrophy conferences. The highly integrated cores and projects of this Center will
accelerate the tempo of discovery in preclinical translational research and broadly impact the care of patients,
from managing individuals to changing treatment paradigms affecting patient groups.

Public health relevance
Overall Project Narrative The University of Iowa Wellstone Muscular Dystrophy Specialized Research Center (MDSRC) promotes the NIH mission through pre-clinical and clinical translational research, focused on the dystroglycanopathies, muscular dystrophies that share hypoglycosylation of -dystroglycan leading to progressive weakness and co- morbidities, including decline in respiratory muscle function. Our MDSRC has a program for successfully training the next generation of muscular dystrophy basic and clinical research investigators, and a nationally recognized biorepository core that makes tissues and cells available to the broad neuromuscular disease research community. The coordinated focus of the three highly integrated cores (administrative, shared resource and training) and two projects (pre-clinical and clinical research) is to facilitate translation of discoveries from basic science research to improve diagnosis and treatment of patients with dystroglycanopathy.